Cell Directed Immunomodulation Therapy as a Bridge to Left Ventricular Device Implantation in Chronic Heart Failure Patients

Abstract
The Problem. Cardiovascular disease is the leading cause of mortality in the US, accounting for 45% of all
deaths. Chronic Heart Failure (CHF) is now understood to be a multi-system disease process involving not only
the cardiovascular system but also the renal, neuroendocrine and immune systems. No effective therapy is
currently available to treat the most severe subset of CHF patients that have progressed to acute
decompensated HF. An innovative approach to reduce the cardio-depressant effects associated with the
chronic inflammatory state of CHF may provide a breakthrough for this disorder. This proposal will evaluate
the safety and probable benefit to improve cardiac or renal function with an immunomodulatory device to
bridge patients to Left Ventricular Assist Device (LVAD) implantation deemed ineligible for this life sustaining
procedure. If the trial is successful, a pathway to commercialization via a Humanitarian Device Exemption
(HDE) would be available for rapid use in this patient population whose life expectancy is days to weeks.
The Product. The Selective Cytopheretic Device (SCD) is an immuno-regulating, extracorporeal, membrane
device targeted to modulate the cardio-depressant effects that are associated with CHF. SCD is a platform
technology focused on immunomodulation of acute and chronic inflammation associated with acute and
chronic organ dysfunction. SCD membranes selectively sequester activated systemic leukocytes as they flow
through the cartridge via an extracorporeal circuit. Pre-clinical results show SCD treatment results in a 25%
improvement in ejection fraction in a canine CHF model. Innovation. SCD is an innovative approach to treat
CHF. Rather than utilizing small molecules to improve myocardial contractility, SCD acts as an
immunomodulatory device to dampen the cardio-depressant effects of the chronic pro-inflammatory state of
CHF. This proposal will provide the first clinical support for the use of immunomodulatory treatment for
chronically inflamed CHF patients. Phase Il Hypothesis. SCD treatment will demonstrate safety and probable
benefit as a bridge to LVAD implantation in a previously ineligible CHF patient population. This Phase Il plan is
based upon results demonstrating SCD treatment improved cardiac contractility in a canine model of CHF and
an ongoing clinical trial demonstrating first in human, proof of concept of successful bridge to LVAD in an
ineligible patient with severe CHF with improvement of cardiac performance. Aim. To expand a current single
center IDE clinical trial to a multicenter trial to enroll 20 patients in 4 centers for evaluation of safety and
probable benefit of SCD treatment for a Humanitarian Device Exemption (HDE) application for a severely ill
patient population to bridge to a life sustaining LVAD implantation. Commercial Opportunity. This proposed
single clinical trial which demonstrates safety and probable benefit will support a HDE submission for FDA
approval and commercialization.

Public health relevance
Narrative The goal of this proposal is to develop an effective therapy for treatment of Chronic Heart Failure (CHF), especially focused on CHF patients that have progressed to acute decompensated heart failure. The therapeutic benefit afforded by the Selective Cytopheretic Device (SCD) for treatment of CHF is based on its ability to improve cardiac function by reducing the chronic inflamed state of CHF which diminishes the pumping action of the heart The relevance of the work in this proposal to the general public is to evaluate this form of therapy in CHF patients who are so severely ill that they are not eligible for heart transplantation or the artificial heart, hoping that this treatment will improve heart function in these patients in order to bridge them to life sustaining treatment with the artificial heart.